Satralizumab as a Treatment for Aneurysmal Subarachnoid Hemorrhage (the STASH Trial)

Subarachnoid hemorrhage due to aneurysm rupture has significant morbidity and mortality. For
those that survive to make it to the hospital, vasospasm can contribute to long-term
detrimental consequences. No definitive treatments exist that drastically reduce the
inflammatory response known to be linked to vasospasm. During part 1 of my R25 funding, IL-6
modulation reduced vasospasm, prevented hydrocephalus, improved behavior, and reduced cell
death. This was published in Journal of Neuroinflammation with correlation to increased IL-6
within human cerebrospinal fluid.
This has now advanced to clinical trial with support from Gene Tech for pharmaceutical grade
drug. This will be a first in human trial that will be the basis for the R25 part 2 funding. This will
be a catalyst for further development of KOS project and advancement from Phase Oto Phase 1
and Phase 2 clinical trials. Both biomarker, behavioral, and imaging data are going to be
assessed as outlined in the proposed project. This project is truly translational and is taking
something from bench to bedside with significant potential impact for improving patient
outcomes.
Project Summary/Abstract

Public health relevance
This project aims to look at targeting neuroinflammation to prevent cerebral vasospasm after subarachnoid hemorrhage. This project will contribute to the application of knowledge to enhance health, lengthen life, and reduce illness and disability among subarachnoid hemorrhage patients to prevent ongoing morbidity and mortality. Project Narrative